Rational Design from Cryo-EM Structures of High-Affinity Ryanodine Receptor Ligands Based on Natural Peptides

SUMMARY
Ryanodine receptors (RyRs), are the Ca2+ release channels of sarcoplasmic reticulum (SR) that play an
essential role in excitaton-contraction coupling of cardiac and skeletal muscle cells. Mutations in the cardiac RyR gene
(RYR2) are associated with catecholaminergic polymorphic ventricular tachycardia (CPVT), an arrhythmogenic
syndrome characterized by the development of adrenergically-mediated ventricular tachycardia and sudden death.
CPVT is clearly an arrhythmogenic disorder stemming from intracellular Ca2+ mishandling caused by RyR2
dysfunction. As such, insights gained from CPVT syndromes benefit our mechanistic understanding of other
cardiomyopathies where RyR2-linked Ca2+ mishandling plays a pivotal role. RyR2 dysfunction brings about
deleterious effects in the heart by inducing SR Ca2+ “leak” and/or spontaneous Ca2+ release (SCR), a sudden, diastolic
Ca2+ bolous of critical mass that triggers arrhythmic activity. Thus, reigning in RyR2 hyperactivity to mitigate SR Ca2+
“leak” and avoid SCR is a primary goal of therapeutic regimes for major cardiomyopathies. A group of globular
peptides termed calcins target RyRs with high affinity and specificity. Imperacalcin (IpCa), the founding member of
the calcin family, engages RyRs by entering through their wide vestibule and binding with exquisite precision to a site
deep in the cytosolic “cap” of the channel, adjacent to the transmembrane region, acting as a wedge that “pushes”
laterally the transmembrane helices that line the channel pore, causing it to open and giving rise to a long-lived
subconductance state. In animal models of CPVT, IpCa penetrates the external membrane of ventricular myocytes
and induces a partial depletion of SR Ca2+, thus preventing SCR and in effect relieving the adrenergically-mediated
Ca2+ overload that triggers Ca2+-dependent arrhythmias. Thus, IpCa behaves naturally as an agonist of RyRs, with
anti-arrhytmic effect in cardiomyopathies where SCR is the primary trigger of arrhythmias, and by rational design of
IpCa analogs capable of closing the natural “grooves” it creates with RyRs, it has the tangible potential to become
the first high-affinity RyR blocker that may prevent SR Ca2+ “leak”. Using cryo-EM structures of calcin-RyR complexes
and a series of functional assays, aim 1 will determine the structural domains of calcins that allow them to bind to
RyRs with exquisite affinity and specificity, and to generate calcin analogs capable of blocking RyR ion conduction.
Aim 2 will use CPVT mouse lines that readily present SCR during sympathetic stimulation and a novel rabbit CPVT
model that presents constitutive SR Ca2+ leak and pathological cardiac remodeling to determine whether native and
mutant calcins are capable of preventing RyR dysfunction-triggered arrhythmias. Our multi-disciplnary program, with
well-defined deliverables and milestones and led by two PIs experts in structural (Van Petegem) and functional
(Valdivia) biology of RyRs, will produce a novel paradigm for the treatment of Ca2+-dependent arrhythmias, an area
severely underserved by existent pharmacotherapy.

Public health relevance
NARRATIVE Genetic mutations in the cardiac ryanodine receptor gene (RYR2) may lead to RyR2 channel dysfunction and lethal arrhythmogenic syndromes, such as catecholaminergic polymorphyc ventricular tachycardia (CPVT), a congenital disease affecting children and young adults with an apparently normal heart, and arrhythmogenic right ventricular cardiomyopathy (ARVC), a structural cardiac disease of right ventricular predominance. RyR2 dysfunction also plays a pivotal role in other major cardiomyopathies such as atrial fibrillation and heart failure; however, there is not yet a single drug in the market specifically designed to control RyR2 dysfunction. In this study, we use cryo-electron microscopy and other cutting-edge techniques to develop a rationalized and novel paradigm for the treatment of CPVT and other RyR2 dysfunction-linked cardiomyopathies, based on calcins, a group of cell permeable peptides that target RyRs with high affinity and specificity.